Collaborative Care to Improve Resilience and Quality of Life among Youth with Non-malignant Blood Disorders

Adolescents and Young Adults (AYAs) with blood disorders are at high risk of poor physical, emotional, and social quality of life. On average, they suffer from seven unique, chronic, distressing symptoms. Over 60% report insufficiently treated pain. AYAs with Sickle Cell Disease (SCD) are at particularly high-risk; their pain, anxiety, depression, and impaired social and cognitive function persist into adulthood. My central hypothesis is that AYAs with serious illness experience poor outcomes in part because the stressors of illness compound the stressors of development. The goal of my research program is to develop interventions to help AYAs navigate those stressors, in turn alleviating suffering and improving quality of life. To date, I have focused on the population of AYAs with cancer and been largely successful; I am currently the PI of 3 NCI R01-funded clinical trials testing the efficacy of a novel resilience coaching program for high-risk teens with cancer or their families.
I am also committed to mentoring the next generation of scientists focused on improving the outcomes of youth with serious illness. I have been the primary research mentor for 21 trainees and early career faculty; all 21 remain involved in patient-oriented research at academic institutions. As a testament to this commitment and my skills, I received the “Excellence in Mentoring” award from the University of Washington in 2021.
Here, I address 2 critical barriers to my continued success: First, few evidence-based psychosocial interventions are ever integrated in routine clinical care. I want to collaborate with clinicians to implement my interventions. Second, care-delivery standards impact intervention-efficacy. I want to robustly collect care-delivery data and better address their impact on intervention efficacy. I will address these barriers via 4 specific learning objectives: (1) Enhance my skills as a mentor, particularly for trainees transitioning to independence; (2) Enhance my skills in collecting and investigating care-delivery data; (3) Develop knowledge in Dissemination and Implementation Science, with a focus on community-based adaptation and engagement; and (4) Develop skills in using the Electronic Health Record (EHR) to assess care-delivery and patient-centered outcomes; and 2 specific research aims: (1) Determine the feasibility and acceptability of a novel, community-based Collaborative Care Model to deliver the Promoting Resilience in Stress Management (PRISM) intervention among N=25 AYAs with SCD; and (2) Leverage the EHR to characterize relationships between care-delivery and outcomes among youth with serious illness. These career development and research activities are significant because they will provide me and my mentees opportunities and skills to maximize the reach and impact of our interventions, in turn improving the physical, emotional, and social quality of life of patients and communities in need.

Public health relevance
Project Narrative In this K24 application, candidate Abby R. Rosenberg, MD, MS, MA proposes to expand her research and mentoring skills to optimize the impact and delivery of promising psychosocial interventions among youth with non-malignant blood disorders. Her research aims are to (1) test the feasibility and acceptability of a community- based, collaborative care model to deliver a positive psychology intervention among teens and young adults with Sickle Cell Disease; (2) leverage the electronic health record to evaluate relationships between social determinants of health and outcomes among children with non-malignant blood disorders; and (3) explore the impact of social determinants of health on psychosocial intervention efficacy using existing data from her R01- funded clinical trials. Her career development goals are to: (1) enhance her skills in collecting and investigating social determinants of health; (2) develop knowledge in dissemination and implementation science, with a focus on community-based adaptation and engagement; and (3) develop skills in using the electronic health record to assess patient-centered outcomes.